STUDIES ON ANTIBODY DEFICIENCY SYNDROMES

The purpose is to conduct studies to elucidate the cellular basis of the immune defects in patients with antibody deficiency disorders in order to better understand the normal immune mechanism involved in the production of specific antibodies.